Engaging new cognitive and motor signals to improve communication prostheses

PROJECT SUMMARY
While current augmentative and alternative communication (AAC) devices present a variety of access
methods for message generation to benefit people with complex communication needs, there still exists a
group of literate adults with severe speech and motor impairments (SSMI) who cannot identify a functional
means for typing, which is an important tool for computer-based communication. In prior NIDCD-
supported research, our research team developed a high performance intracortical brain-computer
interface (iBCI) that decodes movement intentions directly from brain activity. This technology has allowed
people to control a cursor on a computer screen for communication simply by imagining movements of
their own arm. The proposed R01 clinical research will extend this prior work on improving the
performance of iBCI systems, as part of the multi-site BrainGate consortium, and utilizing a new fully-
implantable, wireless system being developed under separate NIH BRAIN Initiative funded project. The
goals of the project are to leverage the discovery of new motor and cognitive signals in human motor
cortex to implement and evaluate three new methods for iBCI typing and general purpose computer use:
(1) an automatic Error Detect and Undo (EDU) system that uses error-related signals from motor cortex,
(2) decoding techniques that create continuous high degree-of-freedom control signals from motor cortex
to increase rates of point-and-click iBCI typing in 3D and 4D as compared with 2D, and (3) decoding
techniques that classify multiple different “click” signals from motor cortex. A rigorous uniform
experimental procedure with clear evaluation metrics will be utilized across all three Specific Aims, in all
three research participants, and at each clinical site using a standardized suite of iBCI tasks, assuring
consistency across sessions and participants. Upon completion, this project will advance both the
capabilities of iBCIs for communication and our understanding of the function of human motor cortex.

Public health relevance
PROJECT NARRATIVE People with severe speech and motor impairment often have difficulty with accessing communication technology, which is increasingly based on interaction with computers. This project aims to develop new methods of interacting with computers via decoding newly discovered brain signals to provide faster and more facile communication. Successful completion of this project could allow this marginalized segment of the US population to once again have the means to manage their health care, form meaningful relationships, have a means for recreation and entertainment, and interact socially with their health care providers and loved ones.